Community Liaison and Recruitment Core

Community Liaison and Recruitment Core(CLRC)
Abstract
CHECA’s Community Liaison and Recruitment Core (CLRC) will play a pivotal role in our ability to achieve
authentic and impactful engagement with our local communities throughout Chicago, one of the most
racially/ethnically diverse large cities in the United States. The overall goal of the CLRC will be to engage these
diverse communities as equal partners in research aiming to both reduce the risk of ADRD (i.e., through
population science research leading to primary prevention) and minimize its negative impacts within these
communities (i.e., health promotion research leading to secondary prevention). The CLRC will achieve this
goal by providing CHECA mentors and mentees with training opportunities and resources focused on best
practices for conducting community-engaged research (Aim #1), and by establishing and facilitating bi-
directional collaborations and communication channels between CHECA scholars and our community
partners (Aim #2). Key internal collaborators for the CLRC will be Senior Leaders from UIC’s Midwest Roybal
Center for Health Promotion and Translation which has a strong track record of successful interventions with
minority older adults, UIC’s Center for Clinical and Translational Science (CCTS) and the School of Public
Health’s Collaboratory for Health Justice (CHJ). Aim #1 of the CLRC will be achieved through a regular cycle of
roundtable discussions between CLRC leadership, CHECA mentors/mentees, as well as community partners,
with the explicit purpose of assessing the CHECA scholars’ unmet training and resource needs with regard to
community engagement. CLRC leads will then work with CCTS, CHJ, and the Leadership and Administrative
Core (LAC) to locate or develop new opportunities and resources to meet these needs. Aim #2 of the CLRC
will be achieved through a regular cycle of research seminars to be held at locations within key communities in
our Chicago catchment areas. These seminars will give CHECA scholars systematic opportunities to share
their research ideas or findings with community members and will give community members the opportunity to
offer feedback. Built into these seminars will be opportunities for community members to receive training on the
research process to aid in their engagement as equal partners.